EVALUATION OF CENTRAL VENOUS CATHETER COMPLICATIONS IN NEWBORN

Comparing the incidence and severity of complications occurring with the use of "Broviac" vs "Per 0 Cath" central venous lines in the NBICU. Prospective tracking of complications occurring with each catheter will be done. Four sites will be cultured; catheter tip, catheter lavage, catheter hub, and skin insertion site to suggest a means by which catheter-related sepsis may be reduced.